Human factors-designed triple test for HIV, HBV, and HCV infection in whole blood using target amplification, signal amplification, and crumpled graphene biosensor readout

Abstract
Access to frequent, accurate, and highly sensitive HIV viral load monitoring is a critical
component of early infection diagnosis, HIV antiretroviral therapy, and routine diagnostic
testing to keep people informed and help them maintain their HIV viral load status. The
prevalence of co-infection with other viruses that present with similar symptoms, such as
Hepatitis B virus (HBV) and Hepatitis C virus (HCV), drives the clinical need for
multiplexed testing from the same blood sample. Although extensive research and
product development has been applied to point-of-care (POC) viral load testing, the
current paradigm of nucleic acid tests and antigen assays is inherently complex, lacks
robustness, and is costly, which prohibits adoption in settings that serve key populations
seeking care in lower stigma locations (e.g., community health centers vs. hospital
settings). We seek to address this societal need, and technological gap, by advancing
testing methods through the development of a microfluidic cartridge, molecular biology
method, biosensor, and detection instrument that will simultaneously detect HIV, HBV,
and HCV viral loads. This POC test will require minimal whole blood volume (100 L),
take <30 minutes for sample-to-answer, and have superior sensitivity to PCR. Our
nucleic acid test performs sample pre-processing in a microfluidic cartridge followed by
virus-specific activation of CRISPR/Cas enzyme that rapidly releases large numbers of
gold nanoparticle reporters that are subsequently captured and detected on crumpled
graphene impedance-based biosensors. Our handheld, inexpensive (<$50) POC
platform communicates its measurements to a mobile device (smartphone or tablet) to
process current/voltage measurements from a custom circuit board. The affordable
estimated cost per test (~$5) is based on our experience using the Additive
Manufacturing approach for cartridge fabrication, combined with the low microfabrication
cost of resistive sensors on silicon. Our preliminary data demonstrate the effectiveness
of nucleic acid extraction from whole blood, the sensitivity/selectivity of the assay
approach, and the sensitivity of the biosensors. The system will be evaluated using a
rigorous tiered approach by spiking target nucleic acid sequences and viruses into buffer
and whole blood for initial characterization of detection limits. We will validate the POC
platform’s ability to detect HIV, HBV, and HCV in whole blood using clinical samples
provided by our hospital collaborators in Illinois. Throughout the development and testing
of the POC test, we will conduct rigorous human factor engineering and acceptability
research with our behavioral scientist collaborators, who will mediate this iterative
process to reflect the needs of clinicians, scientists, healthcare workers, health
technicians, and potential end users represented by a scientific advisory group. The
resulting platform will make a significant impact upon public health to those who lack
easy access to sensitive, inexpensive, and triple rapid viral testing outside of traditional
clinical settings.

Public health relevance
Narrative An important component of ending the HIV, HBV and HCV epidemics is the broad availability of rapid, inexpensive, multiplexed, and ultrasensitive viral load monitoring “triple test” in whole blood that provides the same accuracy as laboratory tests but delivers sample-to-answer results in point of care settings. This project will develop and validate an integrated set of innovative technologies that perform the sample preparation, assay protocol, and electronic biosensor readout within an inexpensively manufacturable microfluidic cartridge that interfaces with a simple, compact, and inexpensive detection instrument. The system performance will be characterized using artificially prepared test samples and validated with clinical specimens, while the design will be iteratively guided by a scientific advisory group to improve access to viral testing.